ASSESSMENT OF SLEEP PARAMETERS IN PSYCHOPHYSIOLOGICAL INSOMNIA

This protocol is designed to compare the assessment of sleep parameters utilizing standard sleep laboratory polysomnographic techniques and a new device which can be worn by a subject in the home setting which assesses sleep by recording head movements and an indirect measure of eye movements.